Advanced Prediction of Emerging Respiratory Decline with the Linshom Continuous Predictive Respiratory Sensor (CPRS)

Abstract:
This Fast-track SBIR application will fund and enable a new approach to respiratory monitoring, continuous
predictive respiratory monitoring (CPRM), that stands to reduce morbidity and mortality due to respiratory
compromise, while reducing health care system costs. Current devices and systems (human and machine) for
respiratory monitoring are responsive by sounding a warning alarm when a patient reaches a threshold of a
physiologic parameter (i.e. SpO2, ETCO2) and the patient is currently or has been in distress. Technological
limitations have prevented the field from moving further in its ability to predict patient decline so that health
care providers (HCPs) are able to intervene and stop or correct respiratory decline. Linshom has developed a
simple, inexpensive solution for continuous monitoring of respiratory functions including RR, TV, MV, I:E ratio,
and apnea detection. Linshom's 510k FDA-cleared Continuous Predictive Respiratory Sensor (CPRS) solves
existing unmet needs mentioned above with a small, portable, and inexpensive sensor and monitor that tracks
RR, TV, MV, seconds since last breath (SSLB), and I:E ratio in real time. These parameters are crucial for
monitoring of patients suffering from both acute and chronic respiratory illness. Unlike other respiratory
monitoring technologies, Linshom offers an operating room-quality respiratory profile at the patient bedside,
which allows health care providers to promptly diagnose emerging respiratory decline and intervene with
appropriate medical care. Timely intervention should reduce morbidity and mortality and result in significantly
improved care for the patient and large savings for the health care system via reduction in rapid response
activation and ICU transfers. Linshom’s unique ability to provide TV (and thus MV) in the non-intubated patient
creates a profile of patient respiratory status previously not available outside of the OR or ICU (and only in
intubated patients).
In this Fasttrack SBIR we will i) Generate clinical data proving Linshom CPRM’s ability to detect (predict) a
respiratory depression episode (RDE) before current standard of care and devices, ii.) Determine optimal times
to set early warning alarms (maximizing sensitivity and specificity) such that HCPs can intervene sooner than
current practice and avoid morbidity and mortality due to respiratory failure, and iv.) Redesign the CPRS into a
miniaturized chip based device enabling the Linshom CPRM to reach more patients by enabling nasal cannula
(and eventually a home monitor) integration.

Public health relevance
Project Narrative This SBIR research will demonstrate a superior method of respiratory monitoring that will be first to enable continuous predictive respiratory monitoring (CPRM) at the patient bedside and in the future at the patient’s home. This research (phase 1 and 2) and innovative product research & development (phase 2) will enable commercialization of the Linshom CPRM that will move the entire field of respiratory monitoring from responsive (too late) to predictive, where patient respiratory decline is identified when health care providers can take action and pre-empt patient decline. This will reduce morbidity, mortality and healthcare expense. The engineering research (phase 2) will re-design and miniaturize the sensor technology allowing these developments to be embedded in multiple additional, smaller form factors (i.e. nasal cannula, home use) to reach more patients in need of continuous, predictive respiratory monitoring.